Tulane National Primate Research Center Emergency Response to COVID-19 Expansion of Outdoor Breeding Corrals

Revised Title: Tulane National Primate Research Center Emergency Response to COVID-19 Expansion of Outdoor Breeding Corrals Revised Abstract: The Tulane National Primate Research Center (TNPRC) one of the largest specific pathogen free (SPF) rhesus monkey breeding colonies in the United States. National need for these high-quality nonhuman primate models exceeds supply, and demand has increased in the face of the current SARS-CoV-2 pandemic. The SARS-CoV-2 pandemic has placed tremendous pressure on established specific pathogen free (SPF) rhesus macaque breeding colonies and threatens the capacity to provide sufficient animals for research. The TNPRC P51 base grant award (P51 OD011104) provides funds to maintain a self-sustaining population of healthy, behaviorally normal, genetically diverse, and well-characterized nonhuman primates for a broad range of research projects. This supplement to the P51 base grant will be used to add a housing enclosure unit and provide financial support for additional breeding animals for population expansion. The benefits realized from this improvement will expand the TNPRC SPF rhesus macaque research infrastructure to assure these colonies are sustainable and able to provide well characterized research models well into the future.

Public health relevance
Project Narrative – Overall The Tulane National Primate Research Center (TNPRC) has a mission to improve human and animal health through basic and applied biomedical research. The Center serves as a national resource for biomedical research that requires the use of nonhuman primates. Hundreds of NIH-funded investigators each year rely on the resources of the TNPRC to conduct their research.